Statistical methods to localize disease heritability and identify biological mechanisms

PROJECT SUMMARY/ABSTRACT Schizophrenia is a psychotic, chronic and disabling disorder, affecting about 1% of the general population. Identifying individuals at risk for developing this disorder is crucial for establishing preventive interventions. So far, the assessment of risk of developing psychosis has been based primarily on clinical features, the accuracy of which is not optimal for development and implementation of preventive interventions. Evaluation of psychosis risk improves when genetic risk is taken into account. Thus, development of robust measure of genetic risk for psychosis offers a possibility of improvement in assessment of psychosis risk. Recent success of genome- wide association studies in schizophrenia allows the calculation of a polygenic risk score that reflects a cumulative impact of common genetic variants on the development of the disorder and related phenotypes. The aim of this study is to examine the performance of such schizophrenia polygenic score on evaluation of psychosis risk in a sample of individuals at high risk of developing psychosis based on clinical features. The examination will extend to the performance of the genetic score in individuals of non-European descent. This will advance our tools for identification of psychosis risk and, consequently, its preventive interventions in diverse populations.

Public health relevance
PROJECT NARRATIVE The parent grant to this Administrative Supplement aims at the analyses of genetic data in order to better understand the associations between genetic variation and traits, focusing on psychiatric disorders. This Administrative Supplement is focused on interpretation and utilization of genetic data in clinical settings, with attention to diverse populations. The methodology for such utilization is based on a process of combining genetic risk for developing a phenotype across common variants in a genome into a single score. The success of this process depends on the availability of good measures of association between genetic variants and a phenotype that are specific to the examined phenotype and population ancestry in which associations are measured. There is a clear consensus that this methodology is sensitive to the choice of both and produces scores of different accuracies when applied to different phenotypes and populations. Currently, the majority of studies providing measures of genetic associations are performed in populations of European ancestry and on phenotypes that overarch several clinical aspects of a disorder, presenting a challenge in their clinical utilization for disorders with complex symptomatology and for populations of non-European ancestry. Many statistical and clinical geneticists are eager for guidance on how to maneuver this challenge. The research agenda proposed here arises from this need. We have an interdisciplinary working group of clinicians, bioinformaticians and geneticists who will be engaging in regular virtual meetings to address the aforementioned challenge, focusing on psychiatric disorders and populations of European and African American ancestry. Under the intellectual supervision of Benjamin Neale, PI of the parent grant, Tetyana Zayats, who worked in applied statistical genetics for over a decade and also has training in medicine, will drive the research agenda forward. Andrew Marin, a computational biologist with experience in relevant methodologies, will perform hands-on analyses.